Tissue-Specific Regulation of Autophagy by PROPPINs

PROJECT SUMMARY/ABSTRACT
In multicellular organisms, disparate cell types use the same cellular mechanisms to perform common and
unique functions. Autophagy is one mechanism that diverse cells use to maintain homeostasis during
development and maintenance of function in adulthood. Misregulation of autophagy has been implicated in
myriad human diseases and disorders; however, relatively little is known about how basal autophagy is
differentially regulated in distinct cell types. PROPPIN (β-propellers that bind phosphoinositides) family
members WIPI1-WIPI4 are critical autophagy components that bind to PI3P, but whose roles in tissue
development versus maintenance are not well understood. This gap in knowledge has prevented
understanding how basal autophagy is regulated in distinct tissues. The long-term goal is to elucidate the
molecular mechanisms that regulate basal autophagy in distinct cell types to identify potential therapeutic
targets for autophagy-related diseases. The overall objective in this application is to uncover how PROPPINs
regulate basal autophagy independently and synergistically, and how that modulation changes during
development and tissue maintenance. The central hypothesis is that PROPPINs differentially regulate basal
autophagy at discrete developmental stages in distinct tissues, leading to divergent control of downstream
cellular functions. The rationale is that identification of how PROPPINs regulate autophagy in distinct cell types
will yield potential therapeutic targets that can be leveraged to treat diverse human diseases. The central
hypothesis will be tested by pursuing three areas of focus: 1) what distinct roles do PROPPINs play during
tissue development and maintenance of function; 2) how do PROPPINs act synergistically and independently
to modulate basal autophagy; and 3) how do posttranslational modifications of PROPPINs regulate basal
autophagy across cells and tissues? In the first area of focus, Caenorhabditis elegans will be used to elucidate
how PROPPINs modulate tissue development versus maintenance of function across distinct tissues. In the
second area of focus, the separate and overlapping roles of WIPI1-WIPI4 in basal autophagy will be dissected
in murine cell culture. Finally, the third area of focus will examine the effects of WIPI2 posttranslational
modifications on basal autophagy in distinct tissues in C. elegans. The research proposed in this application is
innovative because it leverages in vivo microscopy examining endogenous autophagy reporters in the context
of intact animals with advanced cell culture and biochemical techniques to ask how PROPPINs regulate basal
autophagy in distinct tissues during development and adulthood. The proposed research is significant because
it is expected to identify how PROPPINs differentially modulate basal autophagy and cellular functions in
distinct tissues. Ultimately, the knowledge generated by this proposal has the potential to provide new
opportunities for the development of innovative therapies for numerous human diseases.

Public health relevance
PROJECT NARRATIVE Misregulation of autophagy has been implicated in numerous human diseases that stem from a variety of cell and tissue types. Our proposal will elucidate how PROPPIN family members WIPI1-WIPI4 act synergistically and independently in distinct cell types to regulate basal autophagy during development and maintenance of function in adulthood. Thus, the proposed research is relevant to public health and the part of the NIH’s mission that pertains to reducing illness and disability by identifying potential therapeutic targets for treating disparate diseases.